Patient-Reported Outcome Measure (PROM) Utilization to Advance Patient Centered CKD Care

Project Summary
Individuals living with chronic kidney disease (CKD) identify health-related quality of life (HRQOL), including
symptom burden, as a top clinical and research priority; equal to, if not more important than death. Patient-
reported outcome measures (PROMs) are tools to measure health status directly from the patient perspective.
While existing PROMs validly and reliably measure symptoms and HRQOL in people with CKD, evidence
demonstrating how regular use of such PROMs impacts biomedical and patient-reported outcomes is lacking,
limiting the incorporation of PROMs into routine practice. This proposal seeks to demonstrate the clinical utility
of PROMs in the care of persons with advanced CKD, thus facilitating the uptake of PROMs in practice and
ultimately supporting more patient-centered care. We will examine PROM use across two specific domains:
individualized risk stratification and symptom management. First, using data from two large, observational cohort
studies of adults with CKD, we will develop and validate risk stratification models incorporating PROMs for use
in persons with advanced CKD. Aim 1 will test the added predictive value of HRQOL indices to an existing CKD
risk prediction tool for end-stage kidney disease and mortality. Aim 2 encompasses development and validation
of a predictive model for HRQOL in the year following dialysis initiation as the outcome. The resulting models
will enhance prediction of disease trajectory and promote shared decision-making. In the domain of symptom
management, empirical support from other disciplines demonstrates improved HRQOL and decreased mortality
among patients randomized to routine patient self-reporting of symptoms via use of electronic PROMs
(ePROMs), with feedback of patient responses to clinicians. In Aim 3, we will conduct a randomized pilot trial
assessing the implementation and preliminary efficacy of supported PROMs for regular symptom assessment
among people with advanced CKD. 70 adult patients with advanced CKD (eGFR <20 mL/min/1.73m2) will be
randomized (1:1) to an ePROM intervention or usual care. The ePROM intervention consists of patient symptom
reporting using a validated PROM monthly for 12 months and feedback of responses to clinicians with guidance
for symptom management. We will use quantitative and qualitative methods to evaluate implementation (reach,
feasibility, acceptability) and preliminary efficacy (HRQOL) outcomes, with the long-term goal of optimizing the
design of a larger, definitive trial testing the effectiveness of the ePROM intervention on HRQOL in non-dialysis
CKD care. The research aims are integrated into a comprehensive training plan that includes practical mentored
experiences and formal coursework to develop the PI’s skills in evaluating prediction models, designing and
executing clinical trials, and performing mixed methods research with a specific focus on evaluating
implementation outcomes. This skillset will build toward future independent patient-centered research of PROM-
based interventions in pre-dialysis CKD management.

Public health relevance
Project narrative Persons with advanced chronic kidney disease (CKD) often have reduced health-related quality of life and significant symptom burden, which contribute to increased morbidity and mortality in this patient population. Patient-reported outcome measures (PROMs) validly and reliably measure these key patient-centered outcomes, but they are not routinely incorporated into clinical practice. This proposal seeks to quantify the clinical utility of PROM use for individualized risk stratification and symptom management among persons living with advanced CKD, with the aim of increasing PROM uptake in practice and ultimately supporting more patient-centered care.